Analysis Core

PROJECT SUMMARY/ABSTRACT
The UCSF Center for Aging in Diverse Communities (CADC) Analysis Core (AnC), funded since 1997, has
been active in national efforts to advance and propagate methods for conducting health disparities and health
equity research in older adult populations. Specializing in measurement, behavioral interventions, study
design, and statistical and data analysis methods, we have provided methodological training and hands-on
mentoring to numerous early-career investigators (CADC Scientists) and disseminated methodological
resources via publications and the CADC website. To move the field of aging-related health disparities
research forward, identifying the key determinants of health disparities and their mechanisms at multiple levels
is a crucial priority and critical to achieve health equity. Thus, we need to build the capacity of CADC Scientists
in general and specialized methods to explicate health disparities determinants and mechanisms, design and
implement interventions, and ultimately accelerate health equity. Because the complexity and diversity of data
sources and methods in aging-related health disparities research are accelerating, it can be difficult for our
Scientists to identify, select, and develop capacity in these general and specialized methods. The overarching
objective of the CADC AnC is to continue to maximize the scientific rigor of the research conducted by our
Scientists by promoting use of optimal methods and cutting-edge tools. While focusing on our Scientists’ pilot
projects, we will simultaneously help them plan next steps (e.g., NIH proposals to support the next stage of
their research). Given the wide array of health disparities research methods, our team-based training approach
will draw on the complementary expertise of the Scientists, their CADC and non-CADC content mentors, the
AnC, and other experts to optimally build Scientists’ research methods capacity tailored to the Scientists’
programs of aging-related health disparities research. Our specific aims are to: 1) provide group-based training
on topics all Scientists should know regardless of their pilot study methods, including (a) established methods
for aging-related health disparities research, (b) use of publicly-available datasets, and (c) relevant NIH
policies; 2) provide individualized training using a team-based strategy by: (a) determining each Scientist’s
needs for general and specialized methods tailored to their pilot and subsequent research and (b) creating and
implementing a customized training and mentoring plan to meet those needs; and 3) continue to develop
methodological resources to promote and build capacity in utilizing optimal methods in aging-related health
disparities research, and disseminate them through publications and our website. By providing methodological
training/mentoring and consultation, we will increase Scientists’ capacity to conduct rigorous aging-related
health disparities research. By disseminating new methodological resources, we will increase national capacity
to understand mechanisms of health disparities in older adults and develop interventions to achieve equity.